Selective disruption of histone deacetylase complexes using protein interaction modulators

Project Summary
Strategies to identify novel therapeutics typically include targeting enzymatic activities involved in relevant
biological pathways, with the assumption that this approach will most likely identify potent, safe, and bioavailable
drugs. This concept is particularly relevant to the development of epigenetic perturbants such as histone
deacetylase (HDAC) inhibitors, or “HDACis”. All seven FDA-approved HDACis bind in similar ways to
promiscuous deacetylase enzymatic pockets. While such “enzymatic inhibitor” compounds are used successfully
to treat T cell lymphomas and multiple myelomas, they remain limited in addressing other types of cancers.
One of the major limitations of currently available HDACis is that, by systematically targeting HDAC enzymatic
pockets, they show little specificity for various HDAC complexes responsible for the regulation of different
subsets of genes, and consequently, they affect the transcriptional regulation of a large portion of the
transcriptome. Our goal here is to develop an alternative model according to which “protein interaction
modulators” perturb specific protein interactions in subsets of HDAC subcomplexes and thus have much
narrower effects on the transcriptome of treated cells than conventional HDACis. The central hypothesis of this
model is that perturbing specific HDAC subcomplexes rather than all HDAC complexes in a cell might result in
much narrower transcriptional effects and yet confer potent anti-tumorigenic effects (Fig. 1). To test this
hypothesis, we propose the three following specific aims.
Aim 1. To determine the extent to which small-molecule perturbations of non-enzymatic subunits of
HDAC complexes can affect their repressing functions. Our goal is to identify a new class of HDAC
modulators, which, instead of targeting enzymatic pockets, would affect other, more specific functions of HDAC
complexes.
Aim 2. To compare global transcriptomic effects of HDAC non-enzymatic versus enzymatic small-
molecule perturbations. One branch of our central hypothesis is that it should be possible to identify HDAC
complex modulators that result in much narrower transcriptional effects than those observed with conventional
HDAC enzymatic inhibitors. Here we will determine transcriptome-wide effects of HDAC subcomplex modulators
to investigate how widely or narrowly these new compounds affect the transcriptome.
Aim 3. To test the hypothesis that promoter occupancy perturbations of HDAC complexes can potently
abrogate tumorigenic phenotypes. We will test to what extent perturbing specific HDAC subcomplexes rather
than all cellular HDAC complexes, while resulting in much narrower transcriptional effects, might nevertheless
confer potent anti-tumorigenic effects.
In short, we propose that instead of affecting all HDAC activities in the cell as conventional HDAC inhibitors do,
a new class of protein interaction modulators can be identified that affect specific HDAC subcomplexes.

Public health relevance
Relevance to Public Health One of the major drawbacks in using currently available epigenetic perturbants, such as histone deacetylase (HDAC) inhibitors, is that they often affect the transcriptional levels of thousands of genes at once, which greatly hinders their use in treating most human pathologies, at the exception of a few blood cancers. We hypothesize that to widen the use of epigenetic perturbants as potential therapeutics, a new generation of inhibitors needs to be developed with much more specific effects on the transcriptome, corresponding to a paradigm shift from “multigenic” to “oligogenic” HDAC inhibitors. In this application, we propose to develop a novel strategy to identify “oligogenic” HDAC complex inhibitors, investigate how these new compounds affect the transcriptome, and understand the molecular mechanisms underlying these activities, which might in turn help developing a second generation of epigenetic perturbants with improved therapeutic properties.